Expanded SPF breeding colony housing at the Emory National Primate Research Center

Abstract
The robust nonhuman primate (NHP) SIV/AIDS research portfolio at the Emory National
Primate Research Center (ENPRC), which reached $23.8 million in FY2023 alone, has placed
significant and unsustainable demands on the Emory NPRC rhesus macaque SPF breeding
colony. To meet the current and projected future research demand, ENPRC is proposing to
demolish an existing small NHP run housing building at the ENPRC Field Station from 1969 that
needs to be decommissioned, and replace it with a larger run housing building to facilitate
expansion of the SPF breeding colony. The new animal housing proposed will consist of 16
indoor/outdoor run housing areas as well as a cage housing room and clinical support space.
This run housing will provide optimal small group breeding to support SIV/AIDS research by
facilitating targeted genetic breeding for specific research requests, as well as colony
management space needed to optimize breeding. The proposed new animal housing at the
Field Station will allow for significant expansion of the SPF rhesus macaque colony over the
next five years, thus providing additional animals to support the current and projected SIV/AIDS
research program for investigators at Emory NPRC as well as for external collaborators to
address the nationwide shortage of NHPs for research.